Neuropeptide-mediated regulation of antihelminth immunity

PROJECT SUMMARY
Helminth parasites, including hookworms, infect approximately 2 billion people worldwide and represent a
significant public health concern. To combat these parasites, the mammalian immune system has evolved
mechanisms to maintain a delicate balance between promoting beneficial inflammation needed to reduce
parasitic burdens, but also subsequently restricting that inflammation once the infectious threat is eliminated.
When properly regulated, this allows for protective immunity to be achieved without the development of
unwanted immunopathology. It is well established that type 2 inflammation, characteristic of helminth-induced
immune responses in humans and mice, is initiated via the production of type 2 cytokines by group 2 innate
lymphoid cells (ILC2s) and type 2 T helper (TH2) cells. The activation of both innate and adaptive lymphocytes
results in the induction of smooth muscle contraction, eosinophilia, mucus production and the population
expansion of basophils. Despite our knowledge of the factors that promote type 2 inflammation, the
mechanisms that restrict its ability to promote immunopathology remain poorly defined. Our preliminary
studies revealed that helminth-induced ILC2 responses, type 2 cytokine production, lung eosinophilia and
mucus production are significantly elevated following the depletion of basophils. Moreover, depletion of
basophils resulted in dramatic lung pathology and decreased lung function. Strikingly, our new studies also
revealed that ILC2s activated in the absence of basophils failed to upregulate expression of the receptor for the
neuropeptide neuromedin b (Nmb). Further, delivery of Nmb to helminth-infected mice resulted in reduced
ILC2 responses, eosinophilia and mucus production. These data suggest that Nmb is a potent inhibitor of type
2 inflammation. Nmb belongs to the bombesin-like family of neuropeptides consisting of neuromedin B, N, S
and U. Importantly, neuromedin U was recently shown to be an important positive regulator of helminth-
induced ILC2 responses. Collectively, our studies suggesting that Nmu and Nmb operate as neuropeptide
‘rheostat’ that properly balances helminth-induced inflammation. Based on our strong preliminary studies and
generation of novel Nmbr-floxed and Nmur-Cre mouse models, three specific aims will address the following
questions: (i) Do helminth-induced basophils regulate Neuromedin b receptor expression on immune cells, (ii)
Does Nmb restrict the activation of multiple immune cells in a manner that properly regulates helminth-induced
inflammation, and (iii) Do Nmu and Nmb directly counterbalance each other and operate as a neuropeptide
rheostat? Collectively, these studies will interrogate novel mechanisms through which type 2 cytokine-
mediated immunity and inflammation are negatively regulated. Defining the mechanisms through which
basophils initiate a Nmu/Nmb-mediated rheostat may inform new therapeutic strategies to treat helminth-
induced immunopathology.

Public health relevance
PROJECT NARRATIVE Helminth parasites infect approximately 2 billion people worldwide and represent a significant public health and economic challenge. While multiple studies have revealed the mechanisms that promote helminth-induced inflammation, the factors that restrict these responses to prevent unwanted tissue damage remain poorly defined. This proposal will investigate the existence of a neuropeptide-mediated rheostat that functions to properly regulate helminth-induced inflammation and promote optimal outcomes.